Mechanisms underlying circadian gating of stress responses

Project Summary
To better adapt to their environment and align key metabolic and physiological activities, the circadian clock
helps organisms partition specific responses to the most optimal times of the day. In humans, many diseases
are characterized by dampened circadian rhythms and symptoms that cluster at specific times of day. In plants,
gene expression dynamics in response to environmental stimuli is highly dependent on the time of day, a process
referred to as circadian gating. Plants have been an ideal model for investigating circadian gating of stress
responses. However, the key regulators involved, the regulatory mechanisms and the functional relevance of
circadian gating remain poorly understood. Insights from our research in the model Arabidopsis suggest that the
current knowledge of the existing clock proteins is not sufficient to explain the functional mechanisms of gating.
Our central hypothesis is that the clock facilitates dynamic protein/DNA interactions, mRNA fate (storage and/or
degradation), and dynamic protein complex composition depending on the time of the day to regulate stress
tolerance mechanisms. In this proposal, we will continue to leverage the plant model Arabidopsis and a
combination of genetics, genomics, biochemical, and molecular biology approaches to identify key regulators
involved in gating and investigate how the clock manages stress signals to elicit a response that is then
communicated to allow for optimal physiological responses in a changing environment. Plants are an ideal
system to engineer or reprogram temporal control of gene expression through manipulating clock-controlled
genes. Our long-term goal is to leverage innovative approaches to precisely enhance or engineer time of day
specific gene expression responses for positive physiological outcomes. Our research discoveries will bridge the
existing knowledge gaps on how signals are partitioned and modulated by eukaryotic clocks and provide new
insights that can aid in optimizing protocols for stress resilience, disease treatments, and chronotherapy.

Public health relevance
Project Narrative The circadian clock coordination of time of day information is critical for human health and plant adaptation. While a lot is known about fundamental aspects of physiologically relevant temperature signals and clock function, less is known about the circadian modulation of stress temperatures. This research will investigate the time of day gatekeeping mechanisms directing specific gene expression responses to cellular stressors leading to new insights on how eukaryotic clocks strategically partition circadian signals to better align with the environment.